Multidisciplinary Investigation of Antitubulin Heterocycles using Synthesis, Biology, and Structural Analysis

Tubulin is a protein involved in microtubule function, including mitosis, cell shape, migration,
and movement of organelles. Tubulin inhibitors are used in cancer treatments; however, the
current inhibitors tend to be complex molecules, and suffer from toxicity issues, multi-drug
resistance, low solubility, and/or the lack of multi-cancer efficacy. The overall and long-term goal
of this proposal is to use hypothesis-driven rational drug design to develop novel heterocyclic
tubulin polymerization inhibitors.
Using a robust, interdisciplinary mentoring research program with undergraduate
researchers, we previously developed PY-407-C, a furanone-containing molecule that
prevented tubulin polymerization and had nanomolar toxicity on cancer cells. Our 3 independent
but complementary goals are as follows. First, we will characterize previously identified PY
molecules for (a) tubulin binding by molecular modeling, (b) concentration needed to inhibit
tubulin polymerization compared to known inhibitors, and (c) binding to non-tubulin proteins in
order to assess specificity. Second, we will employ rational drug design to identify new
heterocyclic tubulin inhibitors via a hypothesis-driven, multi-disciplinary rational drug design loop
of (1) modeling, (2) from which we will design and synthesize new furanone-based targets, and
(3) assay the resultant compounds for cytotoxicity. Biological results will then drive new
synthetic targets to be modeled, and the loop will be repeated. This aim is innovative in that a
multi-PI proposal involving the work of 3 labs at 2 different primarily undergraduate institutions
(PUIs) will bring together different areas of expertise to tubulin inhibitor design. Furthermore,
many of these approaches and methods are particularly innovative at a PUI. Third, we will apply
and develop modular synthetic methods that give access to designed anti-tubulin heterocycles
through two parallel synthetic strategies by: (1) applying and extending our published work while
(2) investigating innovative strategies that employ C-H activation, thus significantly improving
resource efficiency and potentially extending the substitution patterns available for analogue
synthesis (including NH indole derivatives). Of note, all aims are independent as aim 2 can be
performed with compounds made in aim 3 or by our previously published synthetic routes.
Overall, we will perform basic research to improve anticancer agents while training the next
generation of scientists.

Public health relevance
Tubulin is a critical cellular protein and a common target for cancer treatments. Many of the current anti-tubulin drugs, however, suffer from toxicity issues, multidrug resistance, low solubility, and/or the lack of multi-cancer efficacy. The overall goal of this research, therefore, is to use hypothesis-driven rational drug design to develop novel heterocyclic anti-tubulin drugs that combat these issues and provide more potent and effective therapeutics.